DDT-BMQ-0000100 Qualification of the Plasmodium falciparum 18S rRNA biomarker for malaria-endemic controlled human malaria infection studies

ABSTRACT
Biomarker qualification is a process whereby the analytical and clinical performance of a biomarker is tested to
determine its suitability for a particular Context of Use (COU). Clinical trials of malaria drugs, vaccines, and
other therapeutics benefits from high quality diagnostics, but many of the existing diagnostic modalities such as
rapid diagnostic tests and thick blood smear microscopy are relatively insensitive and/or operator-dependent.
In contrast, molecular diagnostic biomarker testing for Plasmodium falciparum has been shown to be
analytically and clinically sensitive and specific in many settings. In this project, biomarker testing will be
performed on archival samples from controlled human malaria infection studies at malaria-endemic sites and
the data will be utilized to support an expanded Context of Use for the Plasmodium falciparum 18S rRNA
biomarker for these type of challenge studies in malaria-endemic regions.

Public health relevance
NARRATIVE Molecular biomarker testing for Plasmodium falciparum is an analytically and clinically sensitive and specific approach to infection detection. In this project, we will perform biomarker testing on samples from controlled human malaria infection clinical trials and utilize the data to support an expanded Context of Use for the Plasmodium falciparum 18S rRNA biomarker for these type of challenge studies in malaria-endemic regions.